Supporting the SEER Quality Control Activities

These contract costs support quality control activities supporting the Surveillance, Epidemiology and End Results (SEER) program conducted by the Surveillance Research Program of the National Cancer Institute.